Leadership & Administration Core

The Colorado Specialized Center of Research Excellence (SCORE) on Sex Differences and Women’s Health
is focused on Bioenergetic and Cardiometabolic Consequences of the Loss of Gonadal Function. The
overarching scientific goal of the SCORE is to address gaps in knowledge of the impact of gonadal aging on
the regulation of energy homeostasis and metabolism by conducting mechanistically driven research across
the basic-to-clinical translational spectrum. The Colorado SCORE is focused on the increased propensity for
abdominal fat accumulation and the associated cardiometabolic dysfunction that are consequent to the loss of
ovarian function. The overarching educational goal is to engage new investigators in research aligned with
the focus of the SCORE through mentoring and training activities to enhance career development. The
Leadership Administrative Core (LAC) provides infrastructural support that ensures the scientific and
educational goals can be achieved. Major LAC objectives: 1) provide scientific leadership for a translational
and transdisciplinary research program focused on the consequences of the loss of gonadal function that
increase risk for age-related diseases; 2) evaluate the progress and productivity of the SCORE Research
Projects and, if necessary, make decisions about the reallocation of resources; 3) foster collaboration among
the SCORE Research Projects, Pilot Projects, SCORE Scholars, faculty, and staff, 4) promote the generation
of new translational research opportunities related to the focus of the SCORE through the Career
Enhancement Core (CEC) awards and through collaborations with other SCOREs; 5) integrate activities of the
SCORE with closely aligned Centers and Programs at the University of Colorado Anschutz Medical Campus
(CU-AMC), including the Multidisciplinary Center on Aging (MCoA), Ludeman Family Center for Women’s
Health Research (CWHR), Colorado Clinical and Translational Sciences Institute (CCTSI), Nutrition Obesity
Research Center (NORC), and multiple institutional training grants; 6) provide statistical, data management,
and evaluation support for the SCORE Research Projects and Pilot Projects; and 7) provide administrative
support for financial oversight, regulatory oversight, and scheduling and general management of all SCORE
activities. To carry out these objectives effectively, the LAC will include a Director, Associate Director, 8-
member Executive Committee, 3-member Internal Advisory Board (IAB), 3-member External Advisory Board
(EAB), and LAC support staff. The SCORE investigators and advisors have complementary strengths that
elevate the impact of the SCORE both locally and nationally. They are renowned scientists with experience in
interdisciplinary and translational research aligned with the focus of the SCORE, and they hold leadership
positions on strategically important committees, boards, centers, and training grants that enable them to
catalyze SCORE collaborations. The Colorado SCORE team is exceptionally well-positioned to advance
research on sex differences that impact women’s health.

Public health relevance
The decline in sex hormones (estrogen and testosterone) with aging can increase risk for certain diseases; osteoporosis is a well-known example. This is particularly important for women’s health because the loss of estrogen occurs during mid-life, whereas the loss of testosterone in men occurs much later in life. The Colorado Specialized Center of Research Excellence on Sex Differences (SCORE) will advance novel ideas for how the loss of estrogen increases fat gain in the abdominal region, which increases risk for heart disease and diabetes, and strategies that may be effective in preventing this.